Bacterial targeting of the P-glycoprotein/endocannabinoid axis for reducing intestinal inflammation in ulcerative colitis

Project Summary/Abstract
Ulcerative Colitis (UC) is a devastating disease characterized by recurring episodic inflammation of the colonic
mucosa that imposes a significant health and monetary burden on the developed world. Currently a significant
portion of patients with UC are treated with TNFα inhibiting antibodies. Such treatments are burdensome on the
healthcare system financially and pose the risk of significant side effects and frequently lead to the development
of anti-drug antibodies, and consequent infusion reactions, and treatment failure. Consequently, researching
novel cost effective, low risk approaches for treating ulcerative colitis should be of high priority. One approach is
to leverage the microbiome to restore and maintain a non-inflammatory state in the colon, instead of targeting
the systemic immune system. Dysbiosis is a hallmark of ulcerative colitis and leads to consequent dysregulation
of local host immune pathways such as neutrophil transmigration through the intestinal epithelium, which has
been shown to be instrumental in the initiation of mucosal inflammation in UC and its perpetuation through
disruption of the intestinal barrier. The dysbiotic microbes in the colon of patients with UC have been shown to
decrease P-glycoprotein (P-gp) expression. Under homeostatic conditions P-gp inhibits neutrophil transmigration
through maintenance of a transepithelial gradient of endocannabinoids, thereby preventing aberrant
inflammation. Thus, increases in intestinal epithelial cell (IEC) P-gp expression promises to limit inflammation in
UC by preventing neutrophil transcytosis. To this end we must understand the mechanisms by which intestinal
P-gp is regulated. While previous work has shown the microbiome dependence of intestinal P-gp expression,
the specific microbial signals and the underlying metabolic networks have not yet been explored. In this proposal
I will design an optimized microbial consortium to induce P-gp in IECs and dampen colonic inflammation in
ulcerative colitis. Additionally, I study the microbial signals and underlying microbial dynamics that induces P-gp.
In Aim 1 I will determine candidate bacterial species with the potential to regulate IEC P-gp. I will then use these
strains to design and optimize a commensal consortium to induce P-gp when transferred into mice. The use of
such a consortium as a potential bacteriotherapeutic for dampening intestinal inflammation will be studied using
murine inflammatory bowel disease models. In Aim 2 I will study the mechanisms by which microbes
communicate with each other and the host epithelium to induce P-gp. I will use a targeted and an unbiased
approach to determine the bacterial signals and metabolites that upregulate P-gp and study the interactions
between bacterial species that encourage P-gp induction on IECs. Overall, this study will provide insight into
how the human microbiome regulates neutrophil transmigration and consequently intestinal inflammation. The
design of the commensal consortium will serve as a first step in the development of a bacteriotherapeutic for
treatment of ulcerative colitis.

Public health relevance
Project Narrative Ulcerative Colitis is a devastating life-long disease which poses a significant health and financial burden on patients and the healthcare system. This proposal aims to develop a group of microbes, which together dampen aberrant colonic inflammation and explore the specific signals and interactions of intestinal microbes that regulate intestinal neutrophil infiltration and thus inflammation. Upon completion of this project, we will better understand the specific pathways and interactions that maintain intestinal homeostasis, which can be leveraged to develop new bacteriotherapeutic approaches treat ulcerative colitis.